Molecular mechanisms linking epigenetic changes to longevity

Project Summary
Understanding molecular mechanisms that govern the aging process is critical in the face of the ever-increasing
incidence of age-related diseases. Loss of epigenetic regulation with age has emerged as a hallmark of aging,
but little is known about the mechanisms linking chromatin alterations to longevity. Recently, in collaboration with
the Brunet lab at Stanford University, we demonstrated that chromatin changes in the Caenorhabditis elegans
germline, specifically a deficiency in trimethylation of lysine 4 on histone H3 (H3K4me3) via the Complex Proteins
Associated with Set1 (COMPASS), induce changes in expression of mTOR targets which orchestrate a
metabolic shift in somatic tissues to extend lifespan via a specific enrichment of mono-unsaturated fatty acids
(MUFAs). This effect is mediated by the SREBP1/SBP-1 transcription factor, which is activated through COPII-
mediated ER-to-Golgi transport. Recent data in mammals highlighted a critical role for CREB regulated
transcriptional coactivator (CRTC)2 in COPII trafficking, while we have shown that the sole C. elegans CRTC
modulates aging and energetic metabolism. Excitingly, my preliminary data indicate that CRTC-1 specifically
regulates lifespan extension in H3K4me3-deficient animals, establishing a novel role of CRTC-1 in the epigenetic
regulation of aging. My long-term goal is to understand how epigenetic regulation integrates environmental and
internal signals to influence gene expression and downstream cellular processes to promote longevity and
transgenerational benefits. This proposal will use a combination of genetics, microscopy, metabolomics, and
genomic approaches to uncover the molecular mechanisms that mediate H3K4me3-dependent longevity. Aim 1
will define the spatiotemporal requirements of the COMPASS chromatin complex to mediate longevity and its
effectors such as CRTC-1, SREBP1/SBP-1 and mTOR targets. To complement these studies, Aim 2 will identify
the downstream molecular mechanisms and metabolic changes that a specific function of CRTC-1 regulates to
promote H3K4me3-dependent longevity. The independent R00 phase will focus on studying transgenerational
mechanisms downstream of the COMPASS-mTOR-CRTC pathway to promote longevity. The conservation of
all these components will allow me here to translate these findings into mammalian systems to identify the cellular
and physiological responses that epigenetic modifications control to promote longevity. Together, these findings
will serve as the foundation of my research program and will launch the beginning of my independent research
career. My primary mentor, Dr. William Mair will provide important scientific and career guidance to ensure my
success. My advisors and collaborators complement Dr. Mair’s expertise and will help me reach my career and
research goals. The K99/R00 award constitutes a unique opportunity for my advance in the academic track. It
will help me to consolidate an innovative niche in the study of epigenetics of aging and provide me with the
necessary academic and technical training to launch my career as an independent investigator.

Public health relevance
Project Narrative Epigenetic alterations are a hallmark of aging and contribute to a variety of age-related diseases including cancer, neurodegeneration, and metabolic disorders. However, specific epigenetic modifications, such as an H3K4me3 deficiency, promote longevity and induce transgenerational benefits. This project will identify novel molecular mechanisms that govern these positive effects on aging and have the potential to be targeted to protect against the rapidly growing public health burden of age-related diseases.